Perception and Production of Speech Timing in Parkinson's Disease

Project Summary:
Parkinson’s disease (PD) is the second-most common neurodegenerative disease and results in hypokinetic
dysarthria in as many as 90% of individuals, leading to negative mental health outcomes and reduced quality of
life. Although current pharmacological and neurosurgical treatments are effective at treating gross motor
challenges, they do not adequately address speech symptoms. Improving understanding of the underlying
pathophysiology of speech disturbance in PD and factors affecting its variability is critical for developing
individualized treatments that optimize outcomes. Among the most distinctive features of hypokinetic dysarthria
in PD are abnormalities in the timing of speech production, characterized by fast or slow rate, intermittent rushes
of speech, increased or decreased pause time, and increased disfluencies. These features are notably variable
across individuals. People with PD also demonstrate deficits in timing perception including a reduced ability to
discriminate short-duration auditory stimuli and beat-based rhythms. Considering these motor and sensory timing
impairments in PD and the importance of sensorimotor integration in speech, impaired perception of speech
timing may contribute to or exacerbate difficulties in speech timing production in this population. However, there
are significant knowledge gaps regarding the speech timing perception abilities of people with PD and the relation
between perception and production for speech timing in this population. This project will address these gaps
through two specific aims. Aim 1 will comprehensively test speech timing acuity in individuals with PD, examining
acuity for rate, rhythm, and segment duration using both speech and non-speech stimuli. We hypothesize that,
similar to how they perform on non-speech timing acuity tasks, individuals with PD will have reduced acuity for
detecting differences in these speech timing parameters. Aim 2 will examine the relationship between perceptual
timing acuity and speech production timing in people with PD to examine the hypothesis that altered speech
perceptual acuity can explain variability in the timing of speech production. Results will both inform the potential
role of altered timing perception in the communication challenges of people with PD and provide a potential
explanation for the wide variability in the timing speech production in PD. Furthermore, these studies will serve
as a launchpad to explore the neural and behavioral mechanisms underlying speech timing variability in PD and
support the development of novel speech interventions to adequately address speech timing challenges.

Public health relevance
Project Narrative: Hypokinetic dysarthria secondary to Parkinson’s disease is not adequately addressed by current medical interventions, so there is a need to better understand what leads to speech disturbances and how to address them in speech therapy. The overall objective of this project is to investigate the potential impact of speech perception abilities on atypical speech timing in this population. This research will both inform the potential role of altered timing perception in the communication challenges of people with PD and ultimately inform new avenues for speech therapy.